Mechanisms of female germline cyst formation and oocyte selection in mice

Mechanisms of female germline cyst formation and oocyte selection in mice
Abstract
Oocytes are generated within a cluster of interconnected cells termed the germline cyst, which arise in the ovary
as germ cells undergo divisions with incomplete cytokinesis. The germline cyst is a widely conserved structure
from insects to mammals, necessary for the oocyte to gain cytoplasmic content, including mitochondria, from
sister cells. Cytoplasmic enrichment of the oocyte will in turn be needed for this specialized cell to support the
earliest stages of subsequent embryonic development. These processes are best understood from studies in
Drosophila melanogaster, which have guided inquiry into cyst formation and selection of the oocyte by
cytoplasmic enrichment in mammalian systems, revealing several conserved features of the oocyte program.
However, striking differences were also found. Most notably, in contrast to the invariant cyst topology of the fly,
germline cysts are highly variable in mammals, both in terms of size and structure. Moreover, as enrichment of
the fly oocyte is tied to the stereotypic formation of the cyst, these rules cannot be readily applied to mammalian
oocyte selection. As previous studies exclusively relied on the analysis of fixed samples to reconstruct events of
cyst formation and oocyte selection in mice, they have offered limited insight into the mechanisms underlying
these dynamic and variable processes. Here we develop novel genetically encoded fluorescent reporter mouse
lines for key cellular and subcellular features of germline cysts and use our recently established live imaging
setup that allows us to directly visualize the dynamics of cyst formation and oocyte selection within the embryonic
ovary, with unprecedented spatial and temporal resolution. Using these powerful tools, we will first investigate
the mechanisms responsible for generating cysts with variable sizes (Aim 1). We recently uncovered that germ
cells are unexpectedly motile, even as they divide to form cysts, and showed that motility can lead to cyst fracture
and thus regulates cyst size. We will investigate the mechanisms that promote, as well as eventually down-
regulate cell motility, resulting in the stabilization of cysts. Next, we will determine how variable cyst connectivity
patterns arise (Aim 2) by visualizing cell division orientation in relation to intercellular connections and probe the
mechanisms that regulate mitotic spindle orientation and intercellular connection positioning. We will then directly
assay the consequence of these variable cyst features for establishing oocytes (Aim 3). Finally, using a mouse
line with a photoconvertible mitochondria reporter, we will investigate organelle transfer between cysts cells and
determine how variable cyst topologies influence oocyte selection (Aim 4). This work will reveal fundamental
insights into the unique mechanisms of mammalian oocyte formation.

Public health relevance
Narrative Female reproductive cells, termed oocytes, develop from groups of interconnected cells, where the connections allow the transfer of cellular material from so-called nurse cells to a selected cell destined for the oocyte fate. Using the mouse as an accessible mammalian model, we will investigate how interconnected groups of cells form and how material is moved through connections to generate oocytes. Our work will reveal fundamental insights into the unique biology of mammalian oocyte formation and serve as a basis for understanding how errors in these processes lead to fertility problems.